SAFETY AND EFFICACY OF CELLULAR CARDIOMYOPLASTY

Description (Adapted from Applicant's Abstract): The overall goal of this project is to determine whether autotransplantation of skeletal myoblasts into scarred or failing myocardium will lead to long term survival of the myoblast and improvement in systolic and diastolic contractile function. The Principal Investigator plans to use a model of cryoablation injury to the ventricle injecting the myoblasts into the area of damage. In the first aim she will develop a method of labeling the transplanted cells so that they could be detected late and to facilitate determination of longevity. In the second aim, she will determine regional wall motion abnormalities in the area of myoblast transplantation and determine the microenvironment to which the cells are transplanted. In the third aim, she will determine whether the viability of harvested skeletal myoblasts is altered by the presence of congestive heart failure. She will also test the efficacy of myoblast transplantation in a model of coronary ischemia.